2/2 Catheter-Directed Therapy for Chronic DVT (C-TRACT Trial)-DCC

PROJECT SUMMARY
The post-thrombotic syndrome (PTS) is a permanent complication of lower extremity deep vein
thrombosis (DVT). Patients with moderate-to-severe PTS secondary to chronic iliac vein obstruction
experience profound disability and quality of life impairment from pain, massive edema, stasis dermatitis,
and/or venous leg ulcers ("Disabling Iliac-Obstructive PTS” [DIO-PTS]). Currently, there is no evidence-
based therapy for DIO-PTS. Observational studies and a small single-center randomized trial suggest that
imaging-guided, catheter-based endovascular therapy (EVT) that eliminates iliac vein obstruction (stent
placement) and saphenous venous valvular reflux (endovenous ablation) is effective. However, EVT has
risks and is costly.
We therefore plan to do an open-label, assessor-blinded, multicenter, randomized controlled trial (the
Chronic Venous Thrombosis: Relief with Adjunctive Catheter-Directed Therapy (C-TRACT) Study)
that will compare EVT with No-EVT in 374 patients with DIO-PTS. All patients will receive optimal
standardized medical therapy for PTS. The primary outcome will be within-subject improvement in PTS
severity over 6 months, assessed blindly using the Venous Clinical Severity Score (VCSS). Secondary
outcomes include PTS severity (VCSS, Villalta, ulcer healing), and venous disease-specific (VEINES-
QOL) and generic (SF-36) quality of life at 6 and 24 months. A comprehensive health economic analysis
will compare medical costs and estimate the incremental cost-effectiveness of EVT. Safety (e.g. bleeding,
recurrent thrombosis) will be assessed at 2, 6, and 24 months, and venous imaging will be performed to
identify anatomic and physiologic predictors of therapeutic response. The C-TRACT Study will change
clinical practice: if EVT is effective and safe, it will become part of standard therapy for DIO-PTS; if not, a
risky and costly therapy will be avoided. Hence, either study outcome will improve public health and
advance the NHLBI’s mission.

Public health relevance
PROJECT NARRATIVE Moderate-to-severe post thrombotic syndrome (PTS) is very disabling for patients because it causes severe leg pain, swelling, and skin ulceration. PTS is also a major burden to society because it is associated with large health care costs and reduced productivity. Endovascular therapy (EVT), by restoring venous blood flow and function, has the potential to greatly reduce long-term disability and costs from PTS. This study will determine if EVT reduces disability from PTS, improves patients' quality of life, improves ulcer healing, and is a cost-effective treatment.